Anesthesiology & Perioperative Medicine Research Training

Project Summary
This competitive renewal application (5T32GM086270) seeks funding for years 11-15 of our successful T32
postdoctoral training program in anesthesiology and perioperative medicine research training at the University
of Washington. Our primary objective is to provide in-depth research training at the postdoctoral level in cutting
edge (and emerging) areas of biomedical science related to anesthesiology and perioperative medicine.
Trainees from our prior two funding cycles have demonstrated success in this program, producing numerous
peer-reviewed publications, achieving research honors and awards, attaining seed and NIH career
development grant funding, and presenting at scientific conferences. We propose training of four fellows per
year who will spend 2-3 years cumulative time in research in one of a variety of laboratories in the Department
of Anesthesiology and Pain Medicine or in collaborating basic science and clinical departments (e.g.,
Pharmacology, Genetics, Pediatrics, Psychiatry). Research opportunities are offered by 26 NIH-funded faculty
mentors with proven records of success in the training of postdoctoral fellows, with diverse research programs
ranging from laboratory-based science to translational, clinical, and health services research. Core faculty
research leaders will help match trainees to mentors within six major research areas relevant to anesthesiology
and perioperative medicine including (alphabetically): 1) cardiovascular-pulmonary biology, 2) clinical
outcomes research & epidemiology, 3) genome sciences & bioinformatics, 4) neurosciences, 5) pain, and 6)
pharmacology. Aims of the program are: to recruit outstanding diverse postdoctoral trainees from a national
applicant pool; provide trainees with interdisciplinary theories and methods pertinent to their research area;
provide trainees with the practical skills to design and conduct high quality research in anesthesiology and
perioperative medicine (including fundamental research skills, understanding responsible conduct of research,
ability to disseminate research findings, and acquire successful grantsmanship skills and independent funding);
and to create a supportive environment through strong mentorship, a breadth of research opportunities, and
collaboration across departments. We offer a robust didactic program to provide career development skills
which includes monthly seminars in grantsmanship, scientific writing, journal club, and works in progress. All
trainees completed individualized learning plans with their mentors to set goals for their training. Trainee
progress is monitored regularly by an individualized fellow-specific review committee with summary findings
reported to the departmental training grant advisory committee responsible for accepting/hiring fellows and
following their progress. In addition, an external scientific oversight board meets yearly to offer advice to the
program directors on all aspects of the training program. The overall intent of the program is to develop the
next generation of clinician scientist leaders in anesthesiology and perioperative medicine research.

Public health relevance
Project Narrative This application seeks to renew our postdoctoral training program in anesthesiology research at the University of Washington. A crucial need exists for anesthesiology and perioperative medicine investigators with a broad range of theoretical, methodological, and technical knowledge. These attributes are required to advance scientific opportunities from basic, behavioral, population and clinical sciences to novel applications that reduce the burden placed on patients and their families by pain, stress, and perioperative complications.